Neuronal guidance landscape across development and regeneration

Functional neural circuits require accurate wiring by axons. Axonal targeting is mediated by a unique repertoire
of guidance receptors differentially expressed on the axons of given neuronal populations. These receptors
recognize spatially distributed guidance cues across an axon’s trajectory to guide directional axonal growth and
ultimately the formation of appropriate synaptic connections. This complex cell to cell signaling is dynamic,
spatially-regulated, and differs between neuronal populations and their targets. In a nervous system vulnerable
to injury, regeneration of damaged motor axons back to their original muscle targets is essential for recovery of
coordinated movement. Growing evidence demonstrates that axon regeneration is not simply a recapitulation of
development, but that it requires unknown injury-dependent cues. Yet, what are the guidance receptors and cues
that mediate topographically correct axon targeting and what is their spatial distribution? How does the cell
signaling underlying circuit formation differ between developing and regenerating tissues? Understanding the
cellular and molecular mechanisms that mediate regenerative axon guidance represents an important
and unaddressed goal that is relevant to recovery from injury or disease. To fill the existing knowledge gaps, I developed a unique model using the motor innervation of the larval
zebrafish pectoral fin, which is homologous to tetrapod forelimbs. Importantly, this model allows for the in vivo
observation of individual axons and their synaptic targets from development through regeneration. Monitoring
distinct sub-populations of motor neurons reveals that they innervate topographically defined domains in the fin
musculature. To find their targets, motor neuron axons must first navigate to the fin, sort between the abductor
and adductor muscles, and grow to their appropriate muscle domain where they will form functional synapses. I
have previously demonstrated that after laser-mediated axon transection, individual regenerating motor axons
precisely return to their originally-specified muscle and target domains in the fin via unknown mechanisms. The
long-term goal of my research program is to determine the molecular and cellular signaling that enables neuronal
populations to re-establish such precise targeting. Given that each of the stepwise choice points along an axon’s
route requires distinct guidance signaling mechanisms, a candidate-based approach to test the role of individual
guidance cues is not efficient and will not provide a comprehensive understanding of the complex landscape
through which an axon is guided. Thus, a critical foundation to support my research is the generation of a
spatially-resolved single cell transcriptome of the motor neuron sub-populations as well as the cells of the fin that
they target. The Center for Quantitative Biology (CQB) COBRE will advance my research career goals by
providing me with the necessary scientific expertise, technical support, and dedicated mentorship to accomplish
the following aims:
Aim 1: Determine the molecular signature that defines distinct motor neuron populations. The pectoral
fin is innervated by six different motor neuron populations that target distinct domains in the musculature. I
hypothesize that each neuronal sub-population expresses a molecular signature that includes guidance
receptors. Using 10x Chromium single cell RNA sequencing analysis, I will identify RNA transcripts that are
unique to each neuronal population in order to develop transgenic tools to label them selectively. I will also
identify candidate guidance receptors that may drive the unique topographic targeting of each neuronal
population.
Aim 2: Define the spatial organization of guidance cues across development and regeneration. The
specific guidance cues and their spatial organization in the fin are unknown. Moreover, the pectoral fin is
comprised of many cell types, including muscle, perineural glia, Schwann cells, vasculature, and endoskeletal
cells, which could all contribute to the spatial organization of guidance cues that drive axon targeting. First, I will
employ single cell sequencing on pectoral fins to establish the molecular signature of different cell types that
comprise the fin. Then, I will use 10x Xenium spatial transcriptomics to visualize the anatomical location of RNA
transcripts of specific guidance and growth cues at single cell resolution across development and regeneration
of fin innervation. I will combine data from these approaches to resolve the identity of guidance cues, their spatial
organization, and the cell types that express them to fuel hypothesis generation and mechanistic studies.
The CQB COBRE cores and staff will directly support the technical and analytical execution of these
aims. Both the 10x Chromium and Xenium analyzers that perform single cell transcriptomic profiling are housed
in the Single Cell Genomics Core. In collaboration with the Genome Data Science Core, I will establish an
analysis pipeline to integrate information about the neuronal guidance receptors expressed in neuronal subpopulations
(Aim 1) with the guidance cues expressed specifically in the territory they innervate (Aim 2). Future
work that will be competitive for NIH R01 or equivalent funding will leverage this rich dataset and the extensive
toolkit in the genetically-tractable zebrafish to establish a functional role for the molecular drivers of correct axon
targeting across development and regeneration. Insights gained from this work will have broader implications for
deploying cell signaling mechanisms that build, maintain, and repair circuits across the nervous system.